Mechanisms Underlying Impaired Diabetic Wound Healing

ABSTRACT Persistent unresolved inflammation impairs diabetic wound healing. The function and fate of wound monocyte/macrophages (m?) hold the key to the outcome of wound inflammation. This proposal builds on observations originating from live functional wound macrophages (wm?) and wound fluid derived from chronic wounds of patients which were then developed further using experimental models. Given current ambiguity in macrophage nomenclature, and proposed misfit of wm? with the M1/M2 nomenclature, for this proposal we classify wm? based on the pro-inflammatory (m?inf) or pro-resolution/healing (m?heal) functional states. We have reported that i) successful wm? efferocytosis (Eff) helps resolve inflammation; and ii) Efferocytosis severely impaired (Efflo) in wm? of diabetic wounds causing unresolved inflammation, and iii) correction of Efflo with recombinant MFG-E8 (rMFG-E8) in wm? of diabetic wounds resolves inflammation and promotes wound healing. Our laboratory was the first to report a critical role of miRNA-21 in the regulation of wound inflammation. We recently reported the framework of a new paradigm proposing that the plasticity of wm? at the wound-site is a major determinant of the state of wound inflammation. The current proposal seeks to characterize this paradigm with emphasis on two novel aspects: (i) that miR cargo captured in extracellular vesicles (EVs) at the site of wound inflammation determine the fate of wm? and state of inflammation; and (ii) that at the site of diabetic wound inflammation miR is epigenetically silenced (methylated) such that inflammation persists. The following three aims are proposed: Aim 1: Test miR-21 and efferocytosis as critical determinants of monocyte/macrophage fate at the wound-site. §1.1 A unique subset of wm? convert from m?inf → m?F; miR-21 encapsulated in wound-site extracellular vesicles (EV) are delivered to wm? to cause such conversion. §1.2 Another subset of wm? undergoes m?inf→m?heal; this subset plays a critical role in resolution of wound inflammation and healing. Aim 2: Determine how diabetes redirects the fate of wm? causing derailment of healing. §2.1 Diabetic conditions cause miR-21 epigenetic silencing in wm? (miR-21lo). Such deficit, in combination with impaired efferocytosis (Efflo), stalls wm? in m?inf; §2.2 In diabetic wm?, correction of miR-21 and efferocytosis advances diabetic m?inf→m?heal/m?F resuming healing. Novel macrophage-targeted lipid nanoparticle (LNPm?) will correct diabetic miR-21lo. Aim 3: Study live wm? and wound-edge tissue biopsies isolated from diabetic wounds of patients testing whether: §3.1 transition of wm? to m?F (or m?heal) is compromised in poorly controlled diabetics (HbA1c>9) where miR-21 is epigenetically silent; §3.2 correction of miR-21 and efferocytosis advances diabetic wm? from m?inf→m?heal/m?F.

Public health relevance
Project Narrative In the United States, skin wounds affect 6.5 million patients placing a major burden, estimated at US $25 billion annually, on society. Persistent inflammation in wound tissue is a major contributor to wound chronicity, specifically in diabetic ulcers. The proposed project aims to identify novel pathways that regulate the function and fate of wound monocyte/macrophages. These cells are major regulators of wound inflammation. Successful completion of the project will offer critical new knowledge that is clinically relevant and aims at improving management of diabetic wound healing.